Trace Elements in Autopsy Tissues from World Trade Center Decedents

DESCRIPTION (provided by applicant): The goal of this proposal is to test the hypothesis that trace elements from World Trade Center (WTC) dust, gas or fumes remain present in human tissues years after 9/11/2001 and, thus, may be useful in developing biomarkers of cumulative WTC exposure. Our project will work towards the research objective of the Zadroga Act of expanding knowledge of the health effects of the World Trade Center disaster. Using in vivo x-ray fluorescence (XRF), we found that Ti and Sb may have been absorbed and retained in the bones of some WTC survivors. We now wish to pursue this hypothesis further by analyzing trace elements in tissues of deceased individuals enrolled in the World Trade Center Health Registry (WTCHR) who were autopsied by the Office of the Chief Medical Examiner (OCME) of the City of New York. Tissues from approximately 100 index autopsies of WTCHR registrants conducted in 2007-2011 will be available for study, along with tissues from 50 matched control autopsies. Control autopsies will provide measures of background concentrations of trace elements resulting from normal urban life. Interview data from the time of enrollment will be available for index autopsies and will reveal correlations between tissue concentrations of WTC trace elements and WTC exposure estimated from interview responses. We also will compare concentrations of trace elements in different organs of subjects in the WTCHR with those obtained from animals exposed to WTC dust via intratracheal inhalation. Support of the study hypothesis will inspire additional research to develop biomarkers indicative of cumulative exposures to WTC contaminants. Etiologic studies of diseases observed among WTC survivors and medical treatments might be improved with better understanding of the body burden of WTC contaminants.

Public health relevance
If WTC-related trace elements are identified in tissues of individuals at the time of death in 2007-2011, these will be developed into biomarkers indicative of cumulative exposure to WTC contaminants. One approach will be to search for these same elements in hair and fingernails of living WTCHR registrants, while another might be to search via in vivo x-ray fluorescence. Successful development of biomarkers reflective of WTC exposures will be of value to research on the health effects of WTC exposures among first responders, residents and workers, including members of the WTCHR; will be critical to the investigation and attribution of diseases among WTC-exposed individuals; and may aid in the treatment of WTC-associated diseases.